Clinical Protocol and Data Management

CLINICAL PROTOCOL AND DATA MANAGEMENT (CPDM)
ABSTRACT
Clinical Protocol and Data Management (CPDM) is led by Dennis Slamon, MD, PhD (STT), UCLA Jonsson
Comprehensive Cancer Center (JCCC) Associate Director for Clinical/Translational Research. CPDM functions
reside fully within the JCCC Clinical Research Unit (CRU) under the direct authority of JCCC Director, Michael
Teitell, MD, PhD (CMINT). The overarching objective of the CRU and its specific goals are to ensure access to
clinical trials for oncology patients throughout the JCCC catchment area, Los Angeles County (LAC), and
beyond, to further the science of clinical/translational oncology, and to provide new and effective FDA-approved
therapies for widespread use. The CRU provides the necessary infrastructure to execute important and impactful
clinical/translational studies. A strong relationship between the JCCC Director and UCLA research leadership
enables the Center to establish the highest standards for oncology research. The CRU, led by Meghan Brennan,
RN, MSN, ONP, PhD, JCCC Senior Director for Oncology Clinical Research, serves all UCLA/JCCC faculty
conducting cancer-related clinical research. With 240 staff members supporting more than 60 principal
investigators, the CRU oversees and manages more than 500 interventional trials annually. The CRU has
centralized support functions for protocol development, regulatory submission to federal and institutional entities,
study activation and execution, data and safety reporting, monitoring, auditing, and regulatory compliance. The
JCCC, through the Data and Safety Monitoring Board (DSMB) and the CRU Office of Regulatory Compliance
(ORC), provides oversight, data, and safety evaluations for interventional institutional trials. The JCCC ensures
that all clinical trials design is with scientific integrity, having clinical and scientific relevance, addressing safety
issues, and with performance according to state, federal, and institutional policies. Furthermore, the JCCC
applies these standards to all clinical research, from both internal and external sponsors.
Under Teitell, JCCC clinical/translational science and the CRU have grown and undergone transformational
changes in a short period. Working together with Slamon and Brennan, Teitell quickly identified challenges and
the potential for new opportunities influencing trial accrual performance and inclusion. Immediately, Teitell
secured ~$1.8 M in additional institutional funding to develop and support new inclusion initiatives, update and
augment the CRU infrastructure, and add more centralized programs for JCCC members. In the next project
period, the expansion of JCCC clinical research activity with a focus on inclusion and accrual of women,
minorities, children, and underserved populations in LAC and beyond are the highest priorities for Brennan and
Slamon. The JCCC has invested substantially in a more comprehensive inclusion program through four new
diversity initiatives in its catchment area, including the Burbank Gynecology Oncology Initiative, the Van Nuys
Breast Cancer Program, the Olive View Medical Center (OVMC) Program, and Miller Children’s and Women’s
Hospital Long Beach Partnership.